DEFINING THE NEURAL BASIS FOR CHRONIC BLADDER PAIN AND ITS ASSOCIATED COMORBID DISORDERS

Project Summary
The goal of this “Career Development Award” is to provide Dr. Samineni with a mentored
neurourology research experience and to successfully bridge transition from mentored research to
a career as an independent investigator as a neurourologist. Dr. Samineni’s primary goal in the next five
years is to establish as a successful independent scientist conducting neurourology research that
provides mechanistic insights into our understanding of chronic bladder pain and to obtain R01 level
funding. The long-term goal of Dr. Samineni’s research is to independently lead a research
group that investigates new avenues for relief of chronic bladder pain and identify new
therapeutic opportunities through furthering our mechanistic understanding of chronic bladder pain. To
achieve this goal, Dr. Samineni is proposing a project that provides him with significant training in
neurourology. Training plan includes rigorous bench work under the primary supervision of Dr.
Gereau and Dr. Andriole, attending urology focused grand rounds and didactic series, presentations
at national meetings, and training in personnel management, grantsmanship and scientific writing.
This training will enable Dr. Samineni to become an independent scientist in urology and allow him to
be competitive in obtaining an independent NIH research grant (R01). The institutional environment for
career development at Washington University and in the Department of Anesthesiology and Urology
is exceptional. Dr. Evers (Chief of Anesthesiology) pledged his full department commitment. To achieve
Dr. Samineni’s goal, he is proposing a project that provides him with significant training by examining
how maladaptive plasticity in the central amygdala (CeA) circuit contributes to chronic bladder pain in IC/
BPS. Specifically, Dr. Samineni will examine necessity and sufficiency of these circuits in mediating chronic
bladder pain. To test this, Dr. Samineni will use optogenetic techniques to control the activity of the
CeA neurons and determine their relative contribution to bladder pain. This proposal combines Dr.
Samineni’s prior expertise using rodent in vivo work, and pushes forward an innovative combination of
genetics, electrophysiology and circuit dissecting tools. Successful completion of these studies will
identify the maladaptive mechanisms in these circuits for processing chronic bladder pain and will
provide new avenues for developing novel therapies and treatments that would be beneficial for the
treatment of chronic bladder pain. Completion of this K01 award will train Dr. Samineni with
comprehensive, multidisciplinary training in behavioral pharmacology, optogenetics and whole-cell slice
electrophysiology. Furthermore, additional mentored training via the K01 mechanism will allow Dr.
Samineni to bridge the gap in his training with regard to skills relevant to running an independent
research program.

Public health relevance
Project Narrative This proposal will study brain neural circuits mediating chronic bladder pain behavior. Identifying neural mechanisms that underlie chronic bladder pain will provide new opportunities for developing novel therapies that would be beneficial for the treatment of IC/BPS patients.